Data Management & Bioformatics Core

BIOINFORMATICS AND DATA MANAGEMENT CORE (BDM)
SUMMARY/ABSTRACT
The Bioinformatics and Data Management Core (BDM) will provide data management, bioinformatic
processing, and biostatistical analysis of the data created by the Projects as well as the IEC Core of this
program. To accomplish these goals, the Core will provide: 1) database infrastructure, 2) database monitoring
and management, 3) provide data queries for the Projects and other Cores as needed, 4) bioinformatics
processing of raw high-throughput data, 5) biostatistical analysis support, 6) interaction with ImmPort (and
other public data repositories), and 7) ongoing education and career enrichment for staff and study
investigators. This Core will work closely with each Project and the IEC Core to ensure that raw data generated
by each Project will be stored, processed, analyzed, and uploaded in a timely manner for the CPM Core to use
for modeling purposes.

Public health relevance
BDM CORE NARRATIVE The primary functions of the Bioinformatic and Data Management (BDM) Core are to provide 1) data management, 2) bioinformatic and 3) biostatistical analysis support to all the Projects and Cores of this program. The Core is required for proper analysis of data generated within each project, for networking of data across projects for complex analyses by the Computational & Predictive Modeling Core (CPM), and for ensuring the NIH-funded research data is findable, accessible, interoperable, and reusable (i.e., the FAIR principles). Services will be provided in the following areas: · Data monitoring and management. · Database infrastructure and storage. · Data upload into public domain repositories. · Development and implementation of bioinformatics tools and software to create a central data processing platform of high throughput biological data. · Selection of study populations using judicious matching algorithms for enhanced reproducibility of results and mitigation of confounded conclusions. · Biostatistical design and standard analysis of project studies. · Assistance with manuscript preparation. · Education and career development.